Graduate Industrial Hygiene Training Program Grant, University of Arizona

Project Summary/Abstract
The purpose of the University of Arizona’s (UA) Industrial Hygiene (IH) Program is to provide master’s level
graduate training in the core occupational safety and health area of IH. The Program began in 1978 and is
housed in the Mel and Enid Zuckerman College of Public Health (MEZCOPH). There are three tracks: MPH, MS,
and PhD; NIOSH support is requested only for the master’s degree programs. The Program is guided by 14 (11
regular and three adjunct) faculty members and an Industrial Advisory Committee made up of OSH/IH
professionals from the region. There are currently ten masters’ students and twelve doctoral students in the
program. The purpose of this NIOSH Training Project Grant funding application is to financially support IH
master’s students.
A unique strength of the UA IH program is our focus on mining health and safety and relationship with the recently
formed School of Mining and Mineral Resources (SMMR). Arizona and the Southwest have one of the richest
endowments of copper and related commodities on the planet. The mineral resource development industry has
a long history of occupational exposures that lead to workplace injury and illness. Solving these problems and
providing a healthy and safe workplace is the role of the professional IH. The UA IH program is the only program
of its kind in the Southwest so it must provide the bulk of the new IHs for the region. The master's’ programs
require forty-two credit hours to graduate, usually accomplished in two years. Comprehensive coursework is
provided in the key areas of IH including air monitoring theory and practice, occupational safety, physical
exposures, toxicology, and environmental health. Program graduates find employment as OSH professionals in
industry, government, and academia. With education obtained in the program, and depending on their previous
background, they can expect to sit for the CIH and/or CSP exam early in their career.
The program goals for the next budget period are: 1) to continue to provide MPH and MS level IH training to
increase the number of trained IHs, with a particular focus on the Southwest; 2) to continue to provide training
specific to exposures in the mining industry with opportunities for student internships and research projects; 3)
to maintain CEPH accreditation; 4) and to expand training, internship and student research opportunities focused
on microbiological exposures. Diversity is a priority for the program, and the University will continue to support
this through its emphasis on diversity recruiting throughout the southwest.

Public health relevance
Narrative Occupational injury and illness affect millions of workers and their families every year and are tremendous economic burdens on our society. Highly qualified, technically competent, and passionate industrial hygienists are needed to meet our national goal to prevent occupational illness, injury, and fatalities, as described in the DHHS Healthy People 2020.